Novel roles of hepatic fatty acid oxidation

Modified Project Summary/Abstract Section
The liver is central to mammalian metabolism and plays a critical role in providing fuel to other tissues
particularly when food is limiting. People with disparate inborn errors in mitochondrial fatty acid β-oxidation
exhibit life-threatening hypoketotic-hypoglycemia following a fast due to the critical role of fatty acid oxidation to
gluconeogenesis and ketogenesis. To understand the contribution of hepatic fatty acid oxidation to systemic
metabolic dysfunction, we have generated multiple transgenic mice with an altered ability to oxidize long chain
fatty acids via mitochondrial β-oxidation specifically in hepatocytes. Here we will leverage extensive genetic
models to understand the contribution of fatty acid oxidation to hepatic and extrahepatic regulation of hepatic
and systemic metabolic homeostasis. The expectation is that our proposed studies will describe novel
requirements and signaling roles of hepatic fatty acid oxidation that impact the development of obesity and
glucose intolerance.

Public health relevance
Modified Public Health Relevance Section The rationale for these studies is that understanding the roles and requirements of hepatic fatty acid oxidation will provide insight into basic liver physiology. Additionally, these studies will inform the role of this central metabolic pathway in obesity and glucose tolerance. These mechanistic studies may clarify the role of fatty acid oxidation in human pathology and lay the groundwork for clinical interventions.